Targeting extracellular vesicles in neuroblastoma

PROJECT SUMMARY
Neuroblastoma (NB) is the most common extracranial solid pediatric cancer and is one of the leading causes
of cancer-related deaths in children. Despite the current multi-modal treatment regimens, majority of patients
with advanced-stage NBs develop therapeutic resistance and relapse, leading to poor disease outcomes. There
is a large body of knowledge on pathophysiological role of small extracellular vesicles (EVs) in progression and
metastasis of multiple cancer types, however, the importance of EVs in NB was until recently not well understood.
Our recently published studies along with new preliminary data have demonstrated the involvement of EVs in
various aspects of NB pathogenesis, including pre-metastatic niche (PMN) formation, metastasis, and immune
responses. Tumor-derived EVs (TEVs), being important regulators of NB progression, thus could become
efficient targets for developing novel therapies for NB treatment. We have demonstrated that Tipifarnib (a potent,
selective, and orally bioavailable inhibitor of farnesyltransferase that can inhibit the secretion of EVs from cancer
cells) prevents the immunosuppressive effects of TEVs and sensitizes high-risk NB to therapy. We have also
recently reported that SEMA3A mediates the pro-metastatic effects of NB TEV, that depends on SEMA3A
receptor-NRP1. These data support an overarching hypothesis that targeting biogenesis and function of NB-
derived TEV should elicit potent anti-metastatic effects and improve the efficacy of anti-cancer therapy. We will
test this hypothesis in the following Specific Aims: Aim 1: To define the mechanism by which Tipifarnib
suppresses TEV production in NB. We will analyze the stages at which Tipifarnib impedes TEV production and
identify the molecular targets of Tipifarnib involved in the regulation of TEV biogenesis or secretion. Aim 2: To
determine the role and mechanisms of TEV-mediated SEMA3A signaling in NB progression. We will use genetic,
molecular, and pharmacologic approaches to determine TEV-mediated function of SEMA3A in NB pathogenesis.
Mechanisms of TEV-mediated SEMA3A actions will be investigated. Aim 3: Targeting TEV production and
function for NB therapeutics. We will determine the anti-metastatic effects of Tipifarnib and anti-NRP1 antibodies
as mono-agents and in combination to suppress spontaneous or chemotherapy-induced NB metastasis.
Completion of these studies should gain the insight on the importance of TEV in NB metastasis, characterize
the mechanisms of TEV regulation and function in NB, and develop novel strategies to suppress TEV-mediated
NB metastasis.

Public health relevance
NARRATIVE Neuroblastoma (NB) is the most common extracranial solid pediatric cancer and is one of the leading causes of cancer-related deaths in children. Pilot data suggest involvement of tumor-derived extracellular vesicles (TEV) in various aspects of NB pathogenesis. Studies proposed here will characterize the mechanisms of TEV regulation and function in NB and develop novel strategies to suppress TEV-mediated NB metastasis.